Non-coating anti-microbial, anti-host protein deposition, anti-inflammatory urinary catheter

Abstract: Catheter-associated urinary tract infection (CAUTI) is the most common type of
healthcare-associated infection, however currently there is no effective technology to address
the problem. Antimicrobial (anti-biofilm) functionality on the catheter surface is an important field
that has gained a lot of attention; however, commercial applications are limited due to a lack of
infection control outcomes (silver-hydrogel coating) or irritation/discomfort (nitrofural) in clinical
trials. Recent research has now shown that biofilm formation is caused by protein deposition
which will also cause inflammation and immunoreaction. Therefore, the next generation
technology needs both antimicrobial functionalities along with anti-immunoreaction capabilities
to produce a compound effect for infection control. Our company invented a new category of
polymer additive product (HaloAddTM) that can be cost-effectively blended into existing silicon
rubber resins to produce silicone urinary catheters that can provide multiple functions such as
antimicrobial, anti-protein adhesion and anti-inflammation. This phase I effort is geared towards
answering some basic feasibility, efficacy, and safety questions about this approach using both
in vitro and in vivo testing methods. We propose three specific aims:
1) optimize polymer
synthesis and blending parameters to develop HaloAdd-blended silicone rubber formulas with
maximum antimicrobial and anti-fouling efficacy; 2) determine uropathogen attachment
prevention, biocompatibility, and stability of HaloAdd-blended silicone tubes; 3) demonstrate in
vivo that HaloAdd catheter provides measurable anti-inflammation and anti-biofilm outcomes in
a mouse infection model. Success with this phase I effort will lay the groundwork for FDA
clearance for human trials.

Public health relevance
Narrative Development of a new class of antimicrobial and anti-inflammation urinary catheters that can cost-effectively mitigate catheter-associated urinary tract infections. To prove the concept, we will optimize polymer synthesis and blending parameters to develop HaloAdd-blended silicone rubber formulas with maximum antimicrobial and anti-fouling efficacy , determine uropathogen attachment prevention, biocompatibility, and stability of HaloAdd-blended silicone tubes, and demonstrate in vivo that HaloAdd catheter provides measurable anti-inflammation and anti- biofilm outcomes in a mouse infection model.